A Structure-based Drug Discovery Effort to Combat COVID-19 and Future Outbreaks

PROJECT SUMMARY The coronavirus disease 2019 (COVID-19) pandemic that originated in Wuhan, China just a few months ago is advancing at an incredible rate in the United States and the rest of the world. It is impacting everyone's lives, as well as crippling the global economy, health care systems, and more. The disease is caused by the Severe Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) pathogen, and it appears to exert its most devastating effects on people's respiratory and pulmonary systems although recent reports have also cited cardiac complications in otherwise healthy individuals. Based on analyzed data from confirmed cases in the United States between February 12th and March 28th, the Centers for Disease Control and Prevention disclosed that people with substance use disorders such as those with histories of smoking, as well as those with diabetes, chronic lung disease, and heart disease may be at increased risk of developing severe complications from COVID-19. Considering the prevalence of these health conditions in the United States, the global COVID-19 cases approaching 1 million at the time of this writing, the alarming COVID-19 projections for the month of April, the likelihood that COVID-19 becomes seasonal, and the fast pace at which SARS-CoV pathogens evolve into forms with higher cross-species transmission and/or higher affinity for human receptors, there doctors against against is no doubt that the scientific world must mobilize to offer as many solutions as possible to help medical and health care providers save lives. Among these solutions, are suggestions for new medications COVID-19, considering repurposed or may not prove effective COVID-19. against drugs in clinical trials may In this application, we propose to expand the range of potential medications that currently COVID-19 using a rational, structure-based drug discovery approach focused on the virus-receptor recognition mechanism, which regulates its infection, pathogenesis, and host range.

Public health relevance
PROJECT NARRATIVE The ultimate goal of this application is to expand the range of potential medications as abuse to be tested in clinical trials potential therapeutics against COVID-19, and eventually in interactions with drugs to treat substance of or substance of use disorders.